A 0.5 mm resolution total-body small-animal PET

Summary
The key parameters of small-animal positron emission tomography (PET) are its spatial resolution and sensitivity
that determine the ability to image and quantify radiotracers in a small region of the subject at sub-nanomolar
concentrations. However, the applications of small-animal PET have been limited in its application by a
combination of spatial resolution and sensitivity, which hampers the use of PET for a range of applications
including mouse brain imaging, aortic microcalcification and inflammation imaging, high-resolution total-body
dynamic imaging and kinetic modeling studies with using image-derived input function.
The goals of this proposal are 1) to develop a 0.5 mm resolution total-body small-animal PET scanner dedicated
for high-resolution and fast dynamic applications for imaging mouse disease models, and 2) provide a pre-clinical
tool using mouse models to develop, validate, characterize the paradigms and protocols that will feed into human
studies, such as total-body and brain studies. The proposed PET scanner will have 128 depth-of-interaction
(DOI) detectors. The ring diameter and the axial length are 110 mm and 167 mm, respectively, which is designed
to cover the entire body of the mouse and to obtain high resolution and high sensitivity across the entire body.
Dual-ended readout detectors based on linearly-graded silicon photomultipliers (LG-SiPMs) coupled to both ends
of 40 x 40 lutetium yttrium oxyorthosilicate (LYSO) arrays with a pitch size of 0.5 mm and length of 20 mm will
be used to extract DOI information to maintain high and uniform spatial resolution across the entire body of the
mouse. LYSO is chosen due to its high light yield (for high spatial resolution and energy resolution), high stopping
power (for high sensitivity), and fast decay time (high event rate ability).
Dedicated data acquisition electronics for dual-ended readout detectors will be designed for the proposed
scanner by upgrading our well-studied electronics system, and a signal multiplexing readout method will be used
to reduce the 40 signals of each detector to 9 signals (8 for position information and 1 for timing information) to
reduce the cost, complexity, and heat of the readout electronics.
The outcome of this proposal will be a total-body small animal PET scanner with a resolution < 0.5 mm and a
sensitivity ~24.5 % at the center of the field of view. The resolution will be ~0.5 mm and the sensitivity will be
better than 15 % across the volume of the mouse. The spatial/volume resolution is more than 2x/8x better than
currently available small-animal PET scanners with similar sensitivity, and the sensitivity is more than 20x better
than currently available small-animal PET scanners with similar resolution. The proposed scanner can promote
the use of total-body small-animal PET for monitoring biological processes that result in fine structures and
expand the range of applications for this powerful, in vivo, non-invasive and translational imaging modality in
preclinical applications. The PET scanner developed in this proposal is also MRI-compatible and will support
eventual integration inside an MRI scanner for hybrid PET/MRI imaging.

Public health relevance
Narrative Small-animal positron emission tomography (PET) is an in vivo molecular imaging technique widely used in preclinical research, however, the performance of currently available small-animal PET systems is far from reaching the theoretical limit in terms of spatial resolution and sensitivity, which limit its application in high resolution and fast dynamic imaging, such as imaging of mouse brain and obtaining image-derived input functions for kinetic modeling. We propose to develop a total-body small-animal PET system with a ~0.5 mm resolution and ~24.5 % sensitivity to enable high-resolution and fast dynamic imaging using mouse models. The improved performance will promote the use of total-body small-animal PET imaging for monitoring biological processes that result in fine structures and expand the range of applications for this powerful, non-invasive and translational imaging modality in preclinical applications.